Novel sorbents for removal of PFAS from water

Abstract -
PFAS are a ubiquitous and diverse class of toxic, persistent, synthetic fluorochemicals that easily travel in the
environment and have been detected in water resources and water systems globally, earning the moniker
“forever chemicals”. Widespread PFAS contamination has resulted from the production and use of fluorinated
chemicals in consumer and industrial products for many decades, spanning uses including non-stick coated
cookware, firefighting foams, cosmetics, electronic components manufacturing, and many others. While the far-
reaching impacts of PFAS exposure are still under investigation, noted adverse health effects include cancer,
thyroid disease, pregnancy-induced hypertension, and preeclampsia, among others. The annual cost burden of
these health effects has been estimated at $62.6B for the U.S. and €52-84B ($37-59B) in Europe, though even
these figures are noted as likely underestimates. Despite the severity of this problem, no process in standard
wastewater treatment facilities adequately addresses PFAS contamination, enabling the release of PFAS-
containing discharge into surface waters that are used as drinking water sources. Activated carbon (AC) and ion
exchange (IX) resins suffer from low capacity and/or selectivity, especially against short-chain PFAS; reverse
osmosis (RO) suffers from high energy demands and costs despite only a moderate (5-10x) PFAS concentration
factor. Furthermore, today’s PFAS removal sorbents are poorly regenerable, often destined for incineration or
landfill disposal once their PFAS removal capacity is exhausted; sorbents compatible with thermal reactivation
(AC) have relatively low capacity and/or incur high costs and energy-intensive processes. Addressing these
gaps, Sorbenta has developed a patent-protected class of granular sorbents that selectively remove PFAS from
complex waters. By leveraging synergistic ionic and fluorous interactions in a single resin, the technology
specifically targets PFAS removal over background contaminants. In this Phase I project, Sorbenta seeks to
accomplish the following Specific Aims: 1) Enhancing IF sorbent regenerability while minimizing volume of PFAS-
laden waste; 2) Investigating compatibility to treat a range of commercially relevant, PFAS-laden influents; and
3) Developing a suspension process for manufacturing sorbent beads. Successful accomplishment of these aims
will advance the technology toward a marketable solution for PFAS removal and set the team up for success in
Phase II, during which the technology will be scaled up and further tested for selective removal of a broad
selection of PFAS compounds. Completion of this project will allow Sorbenta to deliver an easily implementable
treatment solution that can be appropriately scaled for use across applications including industrial treatment, site
remediation, municipal drinking water treatment, all the way down to at-home point-of-entry and point-of-use
installations.

Public health relevance
Narrative The annual cost burden associated with PFAS exposure is estimated to be at least $62.6B in the U.S., with related disease conditions including cancer, thyroid disease, pregnancy-induced hypertension and preeclampsia, and many others still under investigation. Despite increasing regulation and rising concern, methods to adequately remove PFAS from water remain limited because PFAS are commonly present at orders of magnitude lower concentration than natural organic matter and ions found in water, making PFAS removal equivalent to removing a “needle in a haystack.” Sorbenta’s IF sorbents deliver four key benefits over today’s state-of-the-art, which combined provide performance and economic advantages: 1) high capacity for PFAS removal; 2) selectivity for PFAS in complex water matrices, thus prioritizing capacity for the targeted PFAS compounds; 3) best-in-class, broad capability to capture most long and short PFAS compounds, the latter of which are not effectively removed by most current approaches; and 4) on-site regenerability without apparent loss of performance, enabling advantages in total cost of ownership.